Factors Influencing Pediatric Asthma into Adulthood (FIPA2)

Title: FIPA2 M-PI: Best/Erdei/Torgerson
Project Summary
Pediatric asthma in American Indian (AI) communities of the Northern Plains Region presents a serious
health disparity. While many previous works carried out in minority communities – but not in AI children- looked
at individual level of influences on pediatric asthma and made parents responsible for asthma control, our
study will bring together a more comprehensive and realistic framework. Our novel approach will move the
study from the collected data toward Tribal health policy change. The FIPA2 study is designed to leverage the
previously NIMHD-funded Factors Influencing Pediatric Asthma study (U54MD008164) which successfully
enrolled 324 Cheyenne River Sioux Tribal (CRST) children (age 6-17 years) in 2013-2017. That study also had
a randomized educational clinical trial component (NCT 03302962) and we documented results of that work. In
the FIPA2 study, we will examine the complex interplay between social, environmental and immunological
response to viral respiratory infections an gap in knowledge that remains largely unknown. In this continued AI
community-focused pediatric asthma study, we will test the hypothesis that AI children with asthma have
alterations in immunological response to several viral respiratory infections as compared to those without
asthma. We will also investigate whether social and environmental factors (SEF) significantly contribute to this
disparity through stressed-induced modification of immune state. We will explore the role of viral respiratory
infections (RSV, rhinovirus C, and influenza A and B) and SEF on asthma severity, including frequency of
exacerbations, ER visits/hospitalizations, and use of asthma medications. Aim 1 will identify social and
environmental factors (SEF) that contribute to asthma susceptibility, severity and long-term respiratory health.
Participants will be enrolled at our Missouri Breaks Industries Research Inc. main office by working with
Reservation communities. To achieve enrollment goals, we will also enroll in Rapid City, SD, an urban setting
where AIs also located (12.4% of the city’s population). In Aim 2, we will examine the role of SEF on
immunological and clinical response to viral respiratory infections (VRIs) in AI children with and without
asthma. We will test our hypothesis that interactions with detailed survey measures of SEF with immunological
and clinical outcomes of VRIs, including seasonality of viral responses in participants with and without asthma
are the strongest and most significant predictors in our AI participants. Aim 3 will bring a comprehensive and
vivid community input to this study and will benefit from our local community advisory board (CAB) that
supports the study. We will rely on our own, experienced CBPR-based and bidirectional process evaluation.
We will create a feasible and community-driven asthma prevention framework that will be effective and can be
applied in other AI communities as well.

Public health relevance
The prevalence of asthma among American Indian (AI) children is higher (8.2% as compared to 6.4%) than in non-Hispanic White children, and over 50% of children in the U.S. struggle with uncontrolled asthmatic disease and they also suffer from higher rates of upper and lower respiratory infections. Very little information is available on how Native children are affected by specific viral infection burden and how these immunological factors may be influenced by social and environmental factors (SEF) including adverse childhood events (ACEs), tobacco smoke, and everyday life stressors that may alter immunological state. This community-based study of 550 Tribal children from both urban and rural Reservation areas of South Dakota will target both approaches in order to support culturally appropriate asthma prevention strategies as well as the appropriate local, Tribally-centered family support system in place.